FASEB SRC: The Phospholipids Conference: Dynamic Lipid Signaling in Health and Disease

Summary
This proposal requests partial support for the FASEB Research Conference “The Phospholipids
Conference: Dynamic Lipid Signaling in Health and Disease” to be held July 31-August 5, 2022 at the Wyndham
Grand Jupiter at Harbourside Place, Jupiter, FL, USA. This conference, which began in 1988 and has been
attended biennially by researchers from across the world, is critical to the missions of the NIA because lipids are
critical mediators of signaling, aging, mitochondrial biology, metabolism, and neurodegeneration. Although there
are several conferences that focus on lipid signaling and metabolism, the proposed 2022 FASEB Conference
will have a focus on lipids and aging, longevity, metabolism, and neurodegeneration. This conference will (1)
bring together leading investigators in lipid metabolism and signaling in aging, health and longevity, (2) help train
the next generation of US investigators to bring new advances to lipid and aging discovery sciences, and (3)
promote the improvement of human health by investigating lipid metabolism and signaling in aging and longevity.
The major goals of the 2022 FASEB Conference on Phospholipids: Dynamic Lipid Signaling in Health
and Disease are to: (1) share the most current information on lipid metabolism and signaling in aging, (2) facilitate
new interactions among scientists who do not normally interact in research, (3) promote interdisciplinary
interactions that will lead to new collaborations, and (4) enable understanding and translational research leading
to safe human interventions to improve healthy aging and metabolism. We expect that the new insights that are
formed during the course of this meeting will advance the entire lipid field and especially a focus on lipids in aging
and neurodegeneration as well as longevity, metabolism, and mitochondrial biology. The objective of this
proposal is to obtain funds to support travel and conference fees for scientists, with a special emphasis on junior
faculty, trainees, and those that are underrepresented in science.
The organizing committee consists of four members (Drs. Stahelin, Kiger, Blind, and Merida), who were
nominated by the 2018 FASEB Phospholipids: Dynamic Lipid Signaling in Health and Disease conference
organizers. Each organizer is an expert in one or more of the topics that will be covered during the course of the
meeting. Together, the interdisciplinary committee has a broad range of expertise in lipid research related to
lipids in health and disease. The organizing committee has made calculated efforts to represent major areas of
lipid metabolism and signaling in aging, from metabolic regulation to specific areas of biology and disease. A
workshop on lipids in aging and neurodegeneration will also be held, which we believe will provide 1) training on
lipids and lipid changes with aging, as well as 2) new opportunities for attendees to think about their research
and how it can crossover into the aging field.

Public health relevance
Project Narrative Lipid metabolism and lipid signaling are central tenets of cellular growth, aging and longevity and lipids have recently been implicated in several diseases related to neurodegeneration. In order to broadcast the most recent and significant results in the lipid research field, as well as train the next generation of basic scientists, the Federation of American Societies of Experimental Biology (FASEB) sponsors a biennial conference on “Phospholipids in Health and Disease.” With this R13 application, we seek NIA funding to support scientists and trainees at the interface of lipids and aging, especially those from underrepresented groups, to attend and present at this conference.